Tracking the Mechanisms of Adaptation to Autophagy Inhibition

SUMMARY
Acquired resistance to anti-cancer therapeutics has proven to be one of the largest hurdles in
cancer cell biology because cancer cells have the remarkable ability to adapt to diverse
conditions. For example, when essential metabolic processes are blocked, some cancer cells die,
but subsets of cells can survive and acquire resistance. The organelle recycling process,
autophagy, provides an excellent paradigm to study metabolic adaptations in cancer. Many
cancer cells are addicted to autophagy to maintain homeostasis and regenerate nutrients, but
previous work highlighted the ability of rare cells to rapidly adapt and acquire new dependencies
on alternate metabolic pathways. Rapid and transient adaptations to stress that manifest in the
metabolome, epigenome and transcriptome have been understudied.
This proposal suggests that resistance mechanisms are more complex than just pre-existing
genetic differences between heterogeneous tumor cells, but instead include rapid signaling
events, broad stress and metabolic responses, epigenetic changes, and the acquisition of new
genetic mutations. How and when each of these factors contribute to resistance remains
unknown. Many studies analyze adapted populations after they have undergone selection. The
approach taken here is different: these studies aim to observe the process of selection and
adaptation in action. The proposed projects will develop a set of novel tools and model systems
to track the dynamic interactions of rapid signaling, stress and metabolic responses, along with
transcriptional changes, epigenetic changes, and genetic alterations – all with temporal precision.
Despite decades of studies on therapeutic resistance, fundamental questions remain. For
example, it is critical to determine whether: A) cancer cells undergo a change in state and adapt
in response to a treatment, or B) a treatment simply selects for a pre-existing state that is
heterogenous and already resistant. It is critical to differentiate the dynamics between these two
models to determine whether a given resistance mechanism should be targeted as a combination
therapy (a consequence of Model A), or instead used as a biomarker for patient selection (a
consequence of Model B). Some patients respond remarkably well to autophagy inhibition and
the field is desperate for both biomarkers associated with these patients to improve patient
selection, and for ways to prevent therapy resistance. To this end, these studies will facilitate the
development of better autophagy-targeting cancer therapeutics. Moreover, understanding the
temporally dynamic contributions of different kinds of adaptations will generate new models of
cancer cell drug resistance, beyond those that model autophagy modulation.

Public health relevance
NARRATIVE Acquired resistance still remains a significant challenge in cancer biology, largely because cancer cells have the remarkable ability to adapt. The highly conserved metabolic recycling process, autophagy, provides an excellent paradigm to study metabolic adaptations because cancer cells are often reliant on this process for survival, but rare cells within the population can still find alternative mechanisms to survive loss of autophagy. We will employ temporally precise tools and models to gain a better understanding of the rapid and dynamic response to metabolic perturbations all with the goal to prevent resistance in cancer patients.